Determinants of colonization for commensal skin bacteria

Abstract / Project Summary
Microbiome-based therapies have untapped potential to prevent infection and treat disease—augmentation of
the microbiome might one day promote colonization resistance against pathogens, treat inflammation, and
provide therapeutic metabolites. The grand challenge facing microbiome-based therapies is the
unpredictability of engraftment after application; the degree to and conditions under which human
microbiomes are permissive to colonization of new strains is poorly understood.
This application seeks to define rules of on-human bacterial evolution, ecology, and colonization, towards the
long-term goal of determining the species and therapeutic design modalities that have the highest potential for
long-lasting probiotic therapy. We use healthy human sebaceous skin as a model system because of its
tractability, low complexity, and high similarity across humans, and because states of health are optimal for
applying probiotics without instigating an immune response. We propose to profile five abundant species
which comprise the vast majority of on and across person diversity in this community, at the high genomic
resolution necessary to build rules of on-person engraftment. We hypothesize that our high-resolution, culture-
based approach will reveal commonalities across species in terms of their on-person ecology and evolution,
with differences that inform the niche of each microbe and species-specific therapeutic strategies. We will
leverage a growing collection of longitudinally collected facial swabs from children, adolescents, and adults. In
Aim 1, we will build on and across-person phylogenies to understand how strain stability and transmission vary
across species and life stages. In Aim 2, we will characterize the extent to which each species’ on-person
evolution is dominated by adaptive versus neutral evolution, which will inform the degree to which probiotics
will need to be personalized. In Aim 3, we will identify the role to which interbacterial antagonism controls
colonization by combining genomic data with high-throughput in vitro screening and modeling. This work will
identify common and species-specific rules of colonization in the skin microbiome, and microbiomes in
general, laying the foundation for probiotic strategies with high potential for stable colonization.

Public health relevance
Public health statement / Project narrative The development of long-lasting microbiome therapeutics for the skin and other human microbiomes is limited by a lack of mechanistic understanding of how strains and species colonize, compete, and evolve in human ecosystems. The proposed work will reveal the drivers of stable colonization on healthy human skin and identify challenges and strategies for precision microbiome development.